Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The Administrative (Admin) Core leads the D-ARC by providing a strategic vision and managing fiscal,
administrative, and academic resources. Guided by three advisory boards--both a local and a US/Global
Scientific Advisory Board as well as a Community Action Board--Admin Core leadership implements and
continuously refines the scientific direction of the Center, ensuring maximum impact on science to curb the HIV
epidemic by producing cutting-edge research and growing the Next Generation of investigators. Aim 1. VISION
AND PLAN. Execute a flexible strategic and administrative vision and implement and continuously refine
our strategic plan. The multidisciplinary, diverse Leadership Team of internationally recognized experts in their
fields is well positioned to monitor scientific advancements and funding priorities across disciplines, thus assuring
the Center is abreast of current trends in the field. Through its coordination of activities across the Center, the
Leadership Team will make a positive impact on the research infrastructure of the D-ARC, adding value to
currently funded projects and enhancing novel research opportunities. Aim 2. SUPPORT AND MANAGEMENT.
Support Cores and ensure efficient fiscal, program, and personnel management and monitor and
evaluate progress toward each Core's goals and objectives, with attention to Diversity, Equity, and
Inclusion (DEI) Additionally, the Admin Core manages the internal functioning of the Center, supporting the
Cores, overseeing responsible fiscal management, and monitoring and evaluating progress toward Center aims
and objectives. This robust leadership and efficient management will catalyze innovative training and research
opportunities, adding further value to current resources. Aim 3. IMPLEMENTATION AND IMPACT. Foster
communication that will nurture a collaborative research environment and provide coordination that will
promote Center activities and research and strengthen their impact. Finally, the Admin Core is the focal
point for internal and external communication, advertising and promoting Center activities and opportunities, and
nurturing bi-directional lines of communication with community partners. Clear, consistent communication will
enable transparency, strengthen the D-ARC research environment, and optimize the impact of its activities on
relevant guidelines, policies, and practice. For each aim's activities, the Leadership Team has delineated a set
of clear policies and procedures to achieve the stated goals. Specific metrics are in place by which to evaluate
the outcomes and overall impact of the D-ARC in preparation for an application for a fully funded ARC. Overall,
by developing and overseeing the mission and scientific direction of the Center, ensuring efficient and effective
operational systems to manage resources, and responsibly allocating funding, the Admin Core will catalyze
innovative HIV research and collaborate with research and community partners to implement effective strategies
to end the HIV epidemic.